Mentoring and Patient-Oriented Research on Social Exposures and CVD Risk in Underrepresented Women

PROJECT SUMMARY
This Mid-Career Investigator Award in Patient-Oriented Research is designed to provide Dr. Tené T. Lewis
with protected time and other support to: 1) advance her current program of research, focused on
understanding how social stressors contribute to cardiovascular disease (CVD) risk in underrepresented and
understudied groups of women; 2) accelerate a successful record of mentoring junior patient-oriented
researchers across disciplines, with an emphasis on trainees historically underrepresented in research (e.g.
racial/ethnic minority scientists); 3) enhance her mentoring skills, with a particular focus on transdisciplinary
approaches and best-practices in providing mentoring and support to underrepresented groups; and 4) obtain
training in the examination of biomarkers of ovarian aging, as emerging risk factors for CVD in women.
Mentoring activities will leverage Dr. Lewis’ ongoing involvement in several training programs at Emory
University, including an NHLBI-funded multidisciplinary T32 training grant on cardiovascular health inequities
that she co-directs, the research-track Cardiology fellowship program at the School of Medicine, and the
Master of Public Health and PhD programs in Epidemiology at the Rollins School of Public Health. Mentoring
training will occur via workshops and regular consultation with senior investigators with established track
records in mentoring of patient-oriented researchers from a range of disciplinary and sociodemographic
backgrounds. Training in ovarian aging will build upon Dr. Lewis’ existing collaborations at Emory and with the
Study of Women’s Health Across the Nation (SWAN). Finally, the science proposed in the award will extend
Dr. Lewis’ research in critically important new directions, by examining ovarian aging as a biologically plausible
mechanism that might further contribute to our understanding of how social stressors impact subclinical CVD in
vulnerable subgroups of women (particularly African-American women) highlighting processes occurring at
midlife, when excess rates are most pronounced.

Public health relevance
PROJECT NARRATIVE African-American women have strikingly high rates of cardiovascular disease (CVD) morbidity and mortality, and this is especially true at midlife. Theoretical and non-human primate models suggest that social stressors and ovarian aging may play a role, and the science proposed in this application is designed to examine these associations in a cohort of African-American women. The mentoring and training proposed in this application is designed to foster a supportive environment for the careers of junior patient-oriented researchers interested in social exposures and CVD risk in vulnerable groups of women.